DP21-001 Indiana Pregnancy Risk Assessment Monitoring System

The Pregnancy Risk Assessment Monitoring System (PRAMS) program in Indiana will
continue to greatly aid our goal to reduce infant morbidity and mortality and to promote maternal
health by influencing maternal and child health programs, policies and maternal behaviors
during pregnancy and early infancy. In order to achieve this aim, Indiana needs statistically
representative, high quality data to monitor risk factors for maternal and infant health that
PRAMS offers. The Indiana State Department of Health (ISDH) will continue to utilize these data
to inform public health programs and policies and health care system changes.
The use of PRAMS data will help Indiana continue to track pregnancy outcomes to tailor
programming and follow-up in an effort to prevent preterm births and reduce infant mortality.
We have been able to determine whether target groups are receiving services, and better
understand the barriers to services for certain target groups by analyzing our first year of data.
By being able to assess changes in service use over time we will be able to more quickly
assess whether programs and policies in effect are working and/or require modification.
PRAMS data provide insight into maternal behaviors so that programs can be tweaked to reflect
the most current knowledge regarding the health and intentions of mothers and infants in
Indiana.
The proposed activities in this application consist of conduct of all interviews for the
PRAMS data collection cycle on a monthly basis via mailed Indiana PRAMS questionnaires with
follow-up telephone call attempts for non-respondents when necessary. The Indiana PRAMS
program will continue to be housed in the Maternal and Child Health (MCH) Division at the
Indiana State Department of Health (ISDH). In-house PRAMS staffing will consist of the MCH
Epidemiology Director who will also serve as the PI (10%) and the PRAMS Project
Coordinator/Epidemiologist (100%). ISDH/MCH has selected a contract entity, Kent State
University Survey Research Lab (KSU) through a bid process in order to assist with data
collection. KSU houses a Data Manager who contributes at least 60% of their time to PRAMS.
All staff work together to establish a stable program in order to meet all of the goals and objects
set forth by the CDC. The MCH Division collaborates with the Vital Records Division at ISDH to
ensure data are readily available for sampling through the ISDH/MCH Integrated System. This
system allows for real-time access to Vital Records data which will be provided for monthly
PRAMS sampling.

Public health relevance
Centers for Disease Control and Prevention National Center for Chronic Disease Prevention and Health Prom otion Extram ural Research Program Office Indiana Pregnancy Risk Assessment M onitoring System (PRAM S) Program Com ponent A (Core Surveillance): Project Narrative The Indiana Pregnancy Risk A ssessment Monitoring System (PRA MS) is a surveillance project of the Indiana State Department of Health (ISDH) and the Centers for Disease Control and Prevention (CDC). PRA MS w ill collect state-specific, population-based data on mothers’ attitudes and experiences before, during, and shortly after pregnancy through the distribution of a survey. These data will be used to identify groups of women and infants at high risk for health problems, to monitor changes in health status, and to measure progress towards goals in improving the health of Indiana mothers and infants.